Alleviating stress, loneliness, and social isolation among South Asian families managing breast cancer

PROJECT SUMMARY/ABSTRACT
South Asian heritage and breast cancer are intersecting vulnerabilities for breast cancer survivors and their
family caregivers due to cancer-related stigma and fears, taboos around reproductive organs, and rigid gender
roles. These cultural factors could amplify the stress, social isolation, and loneliness known to affect survivors
and caregivers, and can inhibit breast cancer self-management. Yet, there are no dyadic behavioral
interventions to address these psychosocial needs in the South Asian cultural context. The long-term goal of
this research is to develop a culturally adapted, behavioral intervention to support self-management among
South Asian survivors and their caregivers. The objective here is to develop South Asian Family Approaches to
Disease (SAFAD), a theoretically grounded, behavioral intervention to improve self-management by mitigating
the stress, loneliness, and social isolation among South Asian survivor-caregiver dyads. We will develop
SAFAD by culturally adapting our existing dyadic self-management intervention, web-SUCCEED (web-based
Self-care Using Collaborative Coping EnhancEment in Diseases) which is currently being tested in a clinical
trial with dyads managing chronic and serious illnesses. We propose the following specific aims: Aim 1: Using
generative co-design, develop a prototype of a dyadic self-management intervention for South Asian
breast cancer survivors and caregivers by culturally adapting web-SUCCEED.
Aim 2: Conduct a pilot randomized trial to assess the feasibility of recruitment, retention,
randomization, and measures, and assess the acceptability of randomization and intervention with 30
South Asian survivor-caregiver dyads. We will pursue these aims using an innovative co-design framework
that combines the strengths of community-based participatory research and design thinking. Our multistep
cultural adaptation process will include engagement with South Asian survivors and caregivers with lived
experiences, and community leaders. All activities will be guided by a community advisory board comprising
diverse, multilingual South Asians. The proposed research is significant because it tackles the
underrepresentation of South Asians in cancer survivorship research; the lack of culturally adapted
interventions for South Asians; and the need for evidence-based interventions to combat cancer-related social
isolation and loneliness. The proximal expected outcome is the development of a theory-based, culturally
adapted, dyadic self-management intervention for further testing. The results will have an immediate positive
impact by laying the groundwork for further intervention development, and for prospective, observational
studies to understand the experience of South Asians managing breast cancer, an understudied group that is
at high risk for healthcare disparities.

Public health relevance
Project Narrative The proposed project is relevant to public health because there are no behavioral interventions that address the unique cultural and psychosocial needs of South Asian breast cancer survivors and their family caregivers. We will address this gap by developing a culturally attuned behavioral intervention in close collaboration diverse stakeholders including South Asian breast cancer survivors, South Asian family caregivers, and other key community members. In this way, we will support the NIH-Wide Strategic Plan for Diversity, Equity, Inclusion and Accessibility and National Cancer Institute’s mission to reduce cancer-related health disparities.